Diversity Supplement for Haley Stanczyk

ABSTRACT
Protein phosphorylation defines one of the most important and pervasive regulatory mechanisms in cell
signaling. A precise control of the balance between phosphorylation and dephosphorylation is crucial for living
organisms to maintain normal physiological functions. While protein kinases have attracted a significant amount
of attention given the promise of developing inhibitors for targeted therapies, significant knowledge gaps exist
on the opposing actions of protein phosphatases. The overall objective of this study is to investigate the
molecular mechanisms by which PTPRF, a receptor-type tyrosine phosphatase, regulates Wnt signaling and
normal intestinal homeostasis. A large body of evidence indicates that Wnt signaling is required for the
maintenance of normal intestinal stem cells; and dysregulation of Wnt signaling is often the first step leading to
the development of colorectal cancer. In our efforts to investigate the regulatory mechanisms of Wnt signaling,
we identified PTPRF, a receptor protein tyrosine phosphatase, as a novel positive regulator in the Wnt pathway
that promotes the activation of Wnt signaling upstream of the β-catenin destruction complex. To further determine
the functional importance of PTPRF, we utilized Ptprf knockout mice to investigate if Ptprf-loss alters Wnt
signaling and the proliferation and differentiation of intestinal stem cells in vivo. Our exciting new data showed
that intestinal crypts isolated from Ptprf knockout mice have reduced ability to form organoids, which coincides
with decreased expression of Wnt target genes. In addition, we found that PTPRF interacts and co-localizes with
LRP6 and caveolin upon Wnt stimulation; and CRISPR/Cas9-mediated knockout of PTPRF in 293T cells
attenuates Wnt-stimulated TOP-Flash reporter activity as well as LRP6 phosphorylation. Moreover, we identified
NEDD4L as a novel E3 ligase that controls PTPRF ubiquitination and degradation. The following specific aims
are proposed: 1) to delineate the molecular mechanisms underlying PTPRF-mediated regulation of Wnt
signaling; 2) to determine the role of NEDD4L in controlling PTPRF protein stability; and 3) to define the functional
importance of PTPRF in regulating the proliferation and differentiation of intestinal stem cells in vivo. Results
from our studies will fill an important knowledge gap on how protein phosphatases are involved in regulating
complex biological processes. This supplement will allow Ms. Haley Stanczyk to receive further training in
conducting basic research in cell signaling. Her results will assist in determining the role of PTPRF in regulating
Wnt signaling and intestinal stem cell functions. She will examine the molecular mechanisms by which PTPRF
regulates caveolin-mediated endocytosis of Wnt receptors. Moreover, she will investigate if loss of PTPRF
expression reduces the “stemness” of intestinal stem cells using organoid and mouse models. Ultimately, by
providing new insights into PTPRF-dependent regulation of Wnt signaling, our findings will help identify new
strategies for treating Wnt-driven diseases by using PTPRF as a target.

Public health relevance
PROJECT NARRATIVE Wnt signaling is a rapidly evolving and important field of investigation and new regulators involved in this cascade are continuously being identified. Our study focuses on developing a mechanistic understanding of PTPRF-mediated regulation of Wnt signaling and intestinal stem cell function. Results from our studies will help identify new therapeutic strategies for treating Wnt-driven diseases by using PTPRF as a target.